Probing Heterogeneity of Alzheimer's Disease Using iPSCs

PROJECT SUMMARY
There is an increasing focus on understanding the role of microglia in neurodegenerative disorders including
late-onset Alzheimer’s disease (LOAD), a disease defined by the accumulation of amyloid beta rich plaques and
neurofibrillary tangles containing tau. Microglia are proposed to play a variety of critical roles during disease
progression including synaptic engulfment, cytokine release, and phagocytosis of amyloid beta (Aβ). Further,
recent GWAS studies have implicated innate immune processes in LOAD, supporting the importance of
understanding the neuroimmunological processes underlying the risk and progression of AD. All recent large-
scale GWAS have identified SNPs at the INPP5D locus that are significantly associated with AD. INPP5D
expression is largely restricted to microglial cells in the human adult brain and we have confirmed previous
findings that RNA levels of INPP5D are elevated in AD brain. However, through quantitative western blotting, we
show that protein levels of full length, water-soluble INPP5D are reduced in AD brain. To study the functional
consequences of reduced INPP5D, we used both pharmacological inhibition and CRISPR-Cas9 genome
engineering to lower INPP5D activity in human iPSC-derived microglia. Through unbiased RNA and proteomic
profiling and a series of pharmacological manipulations, we demonstrated that reduction of INPP5D activity
induces changes in immune signaling and, more specifically, the activation of the inflammasome. These studies
have raised important questions that we aim to address in this proposal regarding the constitution of INPP5D in
microglia in the Alzheimer’s brain (aim 1), the molecular mechanism(s) linking INPP5D and inflammasome
activation (aim 2), and the functional consequences of loss of INPP5D activity and inflammasome activation in
microglia on astrocytes and neurons (aim 3). In aim 1, we will utilize quantitative immunostaining, sequential
extraction and western blotting, and ELISA to deeply interrogate INPP5D levels and markers of inflammasome
activation across a large cohort of human brain samples and iPSC-derived microglia cultures. Aim 2 interrogates
candidate pathways that may link INPP5D activity with inflammasome activation that arose from our preliminary
analyses. The first of these involves upregulation of PLA2G7, second through dysregulation of scavenger
receptors and the third through disruption of lysosome function. Finally, in aim 3 we utilize co-culture models of
iPSC-derived neurons, astrocytes and microglia and a conditional INPP5D knock out mouse model to determine
the consequences of reduction of INPP5D levels in microglia on neuron and astrocyte biology in the context of
AD relevant environments. Together, these studies will provide important new insights into our understanding of
the fundamental role of INPP5D in microglia in health and disease, regulation of inflammasome activation in
human microglia, and the consequences of sub-lytic inflammasome activation in microglia on neuron and
astrocyte biology.

Public health relevance
PROJECT NARRATIVE Microglia and neuroinflammation are implicated in the development and progression of Alzheimer’s disease (AD). We aim to deeply interrogate human brain tissue and an experimental model of human brain cells to better understand the processes that result in abnormally high inflammation in the brain in some individuals that result in an elevated risk for Alzheimer’s disease.